Alzheimer's Disease Research Center

Overall Project Summary
The Washington University Charles F. and Joanne Knight Alzheimer Disease Research Center (Knight
ADRC) initiates, fosters, and supports the performance of innovative, cutting-edge research on Alzheimer
disease (AD) and related dementias (ADRD) with regard to the etiology, pathogenesis, diagnosis, treatment,
and prevention of disease. The Knight ADRC's efforts thus fully align with the primary goal of the National
Alzheimer's Project Act of 2011, “to prevent and effectively treat ADRD by 2025”. We provide well-
characterized research participants (persons with symptomatic AD and age-matched controls), their clinical,
psychometric, and imaging data, and their tissue (DNA, CSF, plasma, dermal fibroblasts, iPSCs, brain tissue)
to research projects. We also provide intellectual and financial support to scientists at Washington University,
at other Alzheimer Disease Centers, and the research community nationally and internationally and engage in
formal and informal collaborations, including multi-disciplinary/multi-Center studies and the initiatives
sponsored by the National Institute on Aging, the National Alzheimer Coordinating Center, and the National
Centralize Repository for ADRD. Historically, our Center has focused on the earliest stages of dementia to
identify the initial clinical and pathologic changes that distinguish AD from normal aging. Our approach is
balanced between clinical and basic science domains with emphasis on interdisciplinary efforts. We will
continue our training of students, fellows and junior faculty in clinical and basic science research skills. We will
continue to engage in outreach activities to transfer information on ADRD to lay and professional audiences.
We are committed to assuring that our research cohort reflects the racial diversity of the greater metropolitan
St. Louis area and will continue activities that promote the inclusion of these populations in research.
This renewal application includes seven Cores, plus the new Research Education Component (REC):
A: Administration, B: Clinical, C: Data Management and Statistics, D: Neuropathology, E: Outreach,
Recruitment, and Engagement, F: Biomarker, G: Genetics and High Throughput -Omics.

Public health relevance
Overall Project Narrative Alzheimer disease (AD) has a long asymptomatic stage in which brain changes accumulate silently before finally culminating in symptoms caused by declines in memory and thinking abilities. The Knight Alzheimer Disease Research Center will coordinate and support integrated, cutting-edge transdisciplinary research initiatives to examine the mechanisms that underlie the transition from preclinical to symptomatic AD and that enhance the understanding of the pathobiological disorder.